ISU VDL Ionization Source Proposal

2021 Vet-LIRN Grant for Paperspray Ionization Source Project Summary: The purpose of this application is to purchase a Verispray™ ionization source for mass spectrometry analysis. As analytical technologies improve it is essential for labs to have new and improved analytical equipment. Paperspray mass spectrometry (PSMS) is an approximately 10 year old analytical technology that allows for the rapid analysis of several types of samples in minutes. The paper spray ionization source is interfaced with the mass spectrometer and provides an ambient ionization platform for multiple sample types and compounds. The time-consuming chromatography step of traditional liquid chromatography mass spectrometry (LC-MS) analysis is eliminated with PSMS. The total analysis time for samples with PSMS in under 2 minutes per sample. This new analytical technology would greatly enhance the capacity of both the ISU VDL analytical laboratory and the Vet-LIRN network.

Public health relevance
2021 Vet-LIRN Grant for Paperspray Ionization Source Project Narrative Paperspray mass spectrometry is an ambient ionization technique for rapid detection and quantification of small molecules. This new technology allows labs to quickly respond to emergency situations. Rapid response in a diagnostic laboratory is essential for maintaining the integrity of products that effect human and animal health.